Biomedical Research Training for Veterinarians

ABSTRACT/SUMMARY
Multiple studies by domestic workshops and committees have concluded that the number of veterinary
scientists trained in biomedical and infectious disease research falls far below national needs. The goal of this
training program is to continue to address this personnel gap by providing PhD training in molecular and
mechanistic research methods to enable post-DVM/VMD candidates to conduct translational research.
The training program is built upon our strong history and experience in post-DVM research training
at Colorado State University in the College of Veterinary Medicine and Biomedical Sciences (CVMBS) and
melds molecular, multidisciplinary methodologies with translational application. Critical thinking in experimental
design and data interpretation, manuscript and grant writing, publication, communication skills, and ethical
conduct of research are stressed in this balanced and well-mentored program. New to this application is:
(1) integration with the University of Colorado Anschutz Medical Campus CTSA (Colorado Clinical
Translational Science Institute, CCTSI) TL-1 training program; (2) greater emphasis and goals to increase
diversity, equity, and inclusion; and, (3) additional emphasis on mentoring and professional development, with
a particular focus on trainee NIH K award preparation. An exceptional and diverse External Advisory Board has
been assembled to assist in strategy to further enhance the goals of this renewal application.
The program action plan is to recruit rigorously selected, diverse, post-DVM/VMD candidates and
provide training in translational research applications emphasizing experimental and/or natural disease animal
models. The Program is fueled by an abundant supply of talented candidates and a large, elite faculty of well-
funded mentors representing 18 research concentrations and all four departments of the CVMBS. Mentor
faculty comprise 18% of CVMBS faculty and were awarded $22.8M in direct cost dollars in the most recent
fiscal year. Ninety-four percent of completed trainees since grant inception (34/36) are currently employed in
research related positions; 7 of 8 trainees (88%) who have submitted NIH K Series Career Development
Awards have been funded; and 7 of 39 completed or enrolled trainees are from under-
represented minority groups. All 15 appointees during this grant cycle have been women.
The targeted outcome of the program is to continue to produce DVM/VMD-PhD scientists who emerge
prepared as successful, funded principal investigators and contribute to translational biomedical
research that addresses pressing and emerging problems and challenges in human, animal, and
environmental health (One Health). The intent is that this training program represents a targeted action in
response to a demonstrated need for more translational scientists to fill an alarming deficiency in the
biomedical workforce and contribute to national and global research demands.

Public health relevance
Project Narrative This application requests funds to support post-DVM PhD training in translational biomedical research. Well- trained veterinary scientists bring unique knowledge about comparative biology that significantly contributes to the clinician scientist workforce and aids studies of human health and disease.